A new mucosal adjuvant for augmenting influenza vaccines in elderly

Abstract
This proposal is to investigate a newly developed mucosal adjuvant for its effectiveness in bolstering
influenza (flu) vaccines in the elderly. Current flu vaccines are inefficacious in the elderly owing to the
aged immune system and their poor stimulation of cell-mediated immunity (CMI). A powerful adjuvant
capable of stimulating both humoral and cell immune responses in the elderly should greatly augment
existing flu vaccines, better safeguarding this aging and growing population. We recently engineered a
powerful mucosal adjuvant by encapsulating a natural STING agonist with pulmonary surfactant (PS)-
biomimetic liposomes, named PS-GAMP, based on recent findings that activation of STING, the
stimulator of IFN genes, can vigorously stimulate CMI and humoral immunity. PS-GAMP alongside
inactivated H1N1 vaccine induced a wide spectrum of cross-protection against distant H1N1 and
heterosubtypic H3N2, rgH5N1, and H7N9 viruses as early as 2 days after a single immunization. The
cross-protection lasted for at least 6 months, concurrent with durable lung tissue resident memory (TRM)
CD8+ T cells in young adult mice. We will extend the study to aged mice in this proposal and determine
whether strong CD8+ T-cells (and perhaps CD4+ T cells as well) can be quickly induced by PS-GAMP/flu
vaccine in aged mice. We will monitor a longevity of the heterosubtypic immunity, humoral immune
responses, and lung TRM CD8+ and CD4+ memory T cells as mice age. Because the vaccination does
not involve any replicating vaccine, pre-exiting immunity should have little effect on the efficacy of PS-
GAMP/flu vaccination, which will be investigated to demonstrate significant advantages of the vaccine
over live-attenuated intranasal flu vaccine that is ineffective in the elderly. Secondly, distinguished from
most prominent adjuvants primarily targeting antigen-presenting cells (APCs) or professional immune
cells, PS-GAMP activates both alveolar epithelial cells (AEC) and APCs. It would be interested to learn
whether PS-GAMP-mediated AEC activation can offset the defects of aged APCs, eliciting strong
heterosubtypic immunity in aged mice. The pivotal role for AEC will be also substantiated in ferret model.
Aim 3 will investigate whether PS-GAMP/flu vaccination can be further improved in aged mice by
suppressing inflammaging and/or removing senescence cells. Moreover, a novel, much more potent, and
pan-STING agonist will be explored to enhance PS-GAMP’s adjuvanticity and strengthen its clinical
potential. The study, if successful, would have significant impact on the overall health and quality of the
aged population not only for influenza but also for other respiratory viral infections like Covid-19.

Public health relevance
Narrative The study is to evaluate a newly developed mucosal adjuvant for its ability to augment influenza vaccines in the elderly. Despite wide-spread vaccination programs, influenza-related complications in the elderly remain a major public health concern because the current vaccines are not effective in the over 65 population. The new adjuvant can address this unmet medical need specifically.